SBIR TOPIC 112, FAST-TRACK, INTRAMYOCARDIAL SUTURE ANNULOPLASTY SYSTEM ("MIRTH" AND "SCIMITAR" DEVICES)

NHLBI has developed the Myocardial Intramural Restraint by endovenous interstitial teTHer (MIRTH) procedure and the related Suture via Coronary sinus with Interstitial myocardial navigation for MItral and Tricuspid Annular Reduction (SCIMITAR) procedure to accomplish single- and dual-valve annuloplasty via interstitial navigation of heart muscles entered through heart veins. Clinical evaluation will require the development of purpose-built MIRTH and SCIMITAR devices, which are similar. The contract aims to support the development and commercialization of transcatheter MIRTH and SCIMITAR system.